Mechanism of eNOS Uncoupling in the Renal Microvasculature

DESCRIPTION (provided by applicant): Endothelial dysfunction contributes to microvascular and macrovascular complications of diabetes. A major defense of endothelial cells against vascular injury is endothelial nitric oxide synthase (eNOS), which generates nitric oxide (NO) in the presence of optimal concentrations of the substrate L-arginine and the cofactor tetrahydrobiopterin (BH4). Diabetic nephropathy (DN) is associated with a state of progressive NO deficiency due to eNOS dysfunction, a phenomenon referred to as uncoupling. eNOS dysfunction and decreased bioavailability of NO in the kidney have recently been reported in an experimental model of type 1 diabetes and the protective role of NO generation by eNOS in the kidney has been conclusively established by recent studies showing that eNOS knockout mice made diabetic develop advanced lesions and progressive DN. While these studies established a protective role for eNOS, the mechanism(s) by which eNOS is inactivated in DN are not clearly identified. Understanding the mechanisms of uncoupling of eNOS in type 1 diabetes is essential if the above observations are to be translated to clinical therapeutic regimens aimed at recoupling of eNOS, restoring NO production and decreasing reactive oxygen species (ROS) generation during the course of DN. Our preliminary data show that in isolated glomeruli, where endothelium and mesangium are intact, eNOS generates ROS and lesser amount of NO upon stimulation with high glucose concentration (HG) or angiotensin II (Ang II). eNOS is expressed in glomerular endothelial as well as in mesangial cells and the enzyme generates ROS and less NO after exposure of the cells to HG or Ang II. HG and Ang II also cause a decrease in dihydrofolate reductase and an increase in arginase I protein levels, two enzymes that regulate availability of BH4 and L-arginine, respectively. Ang II and HG result in cell hypertrophy and fibronectin expression in cultured renal cells through generation of ROS via the NAD(P)H oxidase isoenzyme Nox4. Inhibition of Nox4 oxidase using an antisense oligonucleotide therapy reduces diabetes-induced Nox4 expression, renal ROS generation, hypertrophy and fibronectin expression in type 1 diabetic rats. Our central hypothesis is that the ROS generated by Nox oxidases and specifically Nox4 play a pivotal role in eNOS uncoupling in the glomerular mesangium and endothelium and in the kidney in diabetes, thereby resulting not only in the elimination of the protective effect of eNOS, but also converting the enzyme to a phlogistic mediator that further enhances ROS generation. We propose that ROS generated by Nox4 or other Nox oxidases result in oxidation of cysteine residues in the zincthiolate cluster essential for the activity of eNOS, and or decrease the levels of the substrate L-arginine and the cofactor BH4. The role of these pathways in hypertrophy, fibrogenic cytokine expression extracellular matrix accumulation and nuclear factor-kappaB activation will be explored in vitro and in vivo.

Public health relevance
PUBLIC HEALTH RELEVANCE: Diabetes and diabetic nephropathy are major causes of morbidity in the general population. Oxidative stress and decrease in nitric oxide bioavailability contributes to diabetic complications; however, the precise sources of oxygen radicals and the processes involved in these events are not completely defined. It is our hope that identifying specific sources of oxidants will allow targeted therapy to prevent diabetic nephropathy and our long-term goal is to move our findings into the translational arena to treat the patients with specific antioxidant therapy. RELEVANCE: Diabetes and diabetic nephropathy are major causes of morbidity in the general population. Oxidative stress and decrease in nitric oxide bioavailability contributes to diabetic complications; however, the precise sources of oxygen radicals and the processes involved in these events are not completely defined. It is our hope that identifying specific sources of oxidants will allow targeted therapy to prevent diabetic nephropathy and our long-term goal is to move our findings into the translational arena to treat the patients with specific antioxidant therapy. __SpecificAimsTextDelimiter__ Specific Aims Endothelial dysfunction contributes to microvascular and macrovascular complications of diabetes. A major defense of endothelial cells against vascular injury is endothelial nitric oxide synthase (eNOS), which generates nitric oxide (NO) in the presence of optimal concentrations of the substrate L-arginine and the cofactor (6R)-5,6,7,8-tetrahydrobiopterin (BH4) (1-5). Progressive nephropathy is associated with a state of NO deficiency due to eNOS dysfunction, a phenomenon referred to as "uncoupling" (6-9). eNOS dysfunction not only results in decreased bioavailability of NO but also increases the generation of superoxide anion. eNOS uncoupling in the kidney have recently been reported in an experimental model of type 1 diabetes (8, 9). The protective role of NO generation by eNOS in the kidney has been conclusively established by recent studies showing that eNOS knockout mice made diabetic (type 1 or type 2) develop advanced lesions and progressive DN (10-12). While these studies established a protective role for eNOS, the mechanism(s) by which eNOS is inactivated in DN are not clearly identified. Understanding the mechanisms of uncoupling of eNOS is essential if the above observations are to be translated to clinical therapeutic regimens aimed at recoupling of eNOS, restoring NO production and decreasing oxidative stress during the course of DN. Oxidative stress has emerged as a major mechanism contributing to diabetic complications. Hyperglycemia and activation of the renin-angiotensin system are also major contributors to oxidative stress. Our preliminary data show that in isolated glomeruli, where endothelium and mesangium are intact, eNOS generates reactive oxygen species (ROS) and lesser amount of NO upon stimulation with high glucose concentration (HG) or angiotensin II (Ang II). eNOS is expressed in glomerular endothelial (ECs) as well as in mesangial cells (MCs) and these cells generate ROS and less NO upon stimulation with HG or Ang II. HG and Ang II also cause a decrease in dihydrofolate reductase and an increase in arginase I protein levels, two enzymes that regulate availability of BH4 and L-arginine, respectively. Ang II and HG also result in hypertrophy and fibronectin expression in cultured renal cells through generation of ROS via the NAD(P)H oxidase isoenzyme Nox4. In addition, the applicant has recently demonstrated that Nox4 is highly expressed in the kidney in type 1 diabetes and NADPH-dependent ROS generation is increased in the renal cortex and glomeruli of rats with streptozotocin- induced diabetes. Inhibition of Nox4 oxidase using an antisense oligonucleotide therapy reduces Nox4 expression, renal ROS generation, hypertrophy and fibronectin expression in diabetic rats. Our central hypothesis is that the ROS generated by Nox oxidases and specifically Nox4 play a pivotal role in eNOS uncoupling in the glomerular endothelium and mesangium and in the kidney in diabetes, thereby resulting not only in the elimination of the protective effect of eNOS, but also converting the enzyme to a phlogistic mediator that further enhances ROS generation. We propose that ROS generated by Nox4 and other Nox enzymes result in oxidation of cysteine residues and uncoupling of eNOS, and or decrease the levels of the substrate L- arginine and the cofactor BH4. The role of these pathways in hypertrophy, fibrogenic cytokine expression and extracellular matrix accumulation will be explored. Since our Preliminary data indicate that Ang II and HG stimulate ROS generation also by mitochondria, we also wish to understand the interaction between mitochondrial electron-transport chain and uncoupled eNOS and its relevance to HG/Ang II-induced oxidative stress. Our Preliminary data also demonstrate that Ang II and HG activate nuclear factor-κB (NF-κB). We will also determine the role of Nox oxidases and uncoupled eNOS in NF-κB activation and its relevance to HG/Ang II-induced glomerular cell injury. I propose to test these hypotheses by completing the following specific aims: Aim 1a. To characterize the mechanism by which HG and Ang II inactivate/uncouple eNOS in glomerular endothelial cells and mesangial cells and to determine if eNOS uncoupling contributes to cell hypertrophy and matrix production in response to HG and Ang II. Several factors regulate and maintain the integrity of eNOS. eNOS dimers/monomers ratio, a reflection of eNOS allosteric stability, the expression of dihydrofolate reductase (DHFR), the enzyme controlling the synthesis of BH4, an essential cofactor of eNOS and the expression and activity of arginases I and II, the enzymes regulating the amount of the eNOS substrate L-arginine, will be investigated in glomerular MCs and ECs exposed to HG and/or Ang II. The role of uncoupled eNOS in oxidative stress and NO availibility in ECs and MCs, as well as in hypertrophy and fibronectin expression will be validated by using small interfering RNA (siRNA) and cells isolated from eNOS knockout mice as well as cells overexpressing eNOS. Since the presence of excess NOS in conditions where oxidative stress is high lead to peroxynitrite production, the primary role of peroxynitrite in eNOS uncoupling will be examined in cells transduced with adenoviral vector encoding eNOS before and after exposure to HG and/or Ang II. The consequences of these maneuvers on oxidant stress as well as hypertrophy and fibronectin accumulation in response to HG and/or Ang II will be assessed. Aim 1b. To investigate the role of ROS derived from Nox oxidases or mitochondrial electron-transport chain in eNOS uncoupling in endothelial cells and glomerular mesangial cells exposed to HG and Ang II. Two major sources of ROS will be investigated. We will assess the role of the Nox oxidases in the redox- dependent eNOS uncoupling, Arginase I/II and DHFR expression/activity as well as eNOS dimer stability. We will test the hypothesis that eNOS is a target of ROS derived from Nox oxidases, and that uncoupled eNOS amplifies and maintains oxidative stress in glomerular ECs and MCs exposed to HG and Ang II. Nox NAD(P)H oxidases with major emphasis on Nox4 will be investigated as source of ROS. siRNA or antisense oligonucleotides (AS) will be used to neutralize the Nox oxidases. The consequences of downregulation of Nox oxidases on eNOS dimers/monomers ratio, the expression of dihydrofolate reductase (DHFR), and the expression and activity of arginases I and II in cells exposed to HG and Ang II will be determined as in the first Aim. The role of Nox oxidases in the production of peroxynitrite in cells exposed to HG and/or Ang II will also be assessed. Second, we will dissect the contribution of mitochondrial electron transport chain as a source of ROS that uncouples eNOS. Mitochondrial dysfunction characterized by decreased substrate consumption and enhanced ROS generation will be explored. These experiments will be performed in mitochondria isolated from mesangial cells or endothelial cells exposed to Ang II and/or HG. The role of the mitochondria will be documented in cells depleted of mitochondrial DNA that encodes proteins of the respiratory complexes. Aim 1c. To investigate the mechanism by which ROS generated by Nox oxidases, mitochondria and uncoupled eNOS modulate mesangial cell hypertrophy and matrix accumulation, and specifically to determine the role of the transcription factor NF-κB in mediating these effects. The relationship between Nox oxidases and mitochondrial electron-transport chain and eNOS uncoupling including their position in the oxidative pathway engaged by HG and Ang II to regulate cell hypertrophy and matrix expansion will be determined. The role of ROS generated by Nox oxidases, mitochondria or uncoupled eNOS in NF-κB activation and subsequent transcription of genes that mediate the pathological manifestations of DN will be explored in cultured glomerular cells. The fibronectin promoter contains a consensus sequence for NF-κB. The consequence of manipulations of the parameters controlling eNOS function/dysfunction on NF-κB activity will be evaluated. The role of uncoupled eNOS in mediating the effects of HG and Ang II on NF-κB, fibronectin expression and parameters of endothelial and mesangial cell injury will be confirmed using siRNA and cells from eNOS knockout mice as well as cells overexpressing the eNOS described in Aim 1. Aim 2a. To explore the role of ROS generated by Nox oxidases and/or mitochondria in eNOS uncoupling and subsequent functional and structural alterations in the kidneys of rats with type 1 diabetes. The interplay between Nox oxidases and eNOS will be investigated in vivo. The consequence of Nox isoforms downregulation by AS administration on eNOS dysfunction will be determined. Evidence for and mechanism of eNOS uncoupling (i.e. loss of dimer stability, diminished BH4/L-arginine levels, alteration of DHFR and arginase expression/activity) together with decreased NO availability, NAD(P)H oxidase activation, expression of Nox oxidases, mitochondrial dysfunction and ROS/peroxynitrite generation will be assessed at 2 4 and 7 months of diabetes. We will determine the effect of the administration of antisense oligonucleotides to neutralize specific Nox oxidases on the activity of eNOS, ROS generation and NF-κB activation in glomeruli. Creatinine clearance, blood pressure, urine albumin excretion and protein excretion will be measured. Immunohistochemistry and Western blotting will be used to assess structural changes in the glomerulus including matrix protein expression, expression of selected cytokines including TGF-ss and connective tissue growth factor (CTGF). Aim 2b. To further explore the role of eNOS uncoupling and the resulting oxidative stress in the pathogenesis of diabetic nephropathy. The role of eNOS dysfunction will be examined in vivo by inducing type 1 diabetes in transgenic mice overexpressing eNOS in the endothelium. We will determine if superimposing diabetes in the setting of eNOS excess causes further increase in oxidative stress in the endothelium of the transgenic animals via the formation of peroxynitrite resulting from the interaction of superoxide with the high levels of NO. We will compare the severity of diabetic kidney disease in these mice with that in diabetic wild type mice after 2, 4 and 7 months of diabetes. Biochemical, functional and morphological parameters as in 2a will be investigated. Euglycemia is a difficult goal to achieve and blockade of the renin-angiotensin system may be incomplete. Understanding mechanisms of eNOS inactivation is fundamental in developing strategies for rational intervention. Therefore, inhibition of specific Nox-containing NAD(P)H oxidases or administration of L-arginine and or tetrahydrobiopterin may become viable therapeutic interventions to complement traditional therapy to prevent or reverse the pathological changes associated with diabetic nephropathy.